Molecular, genetic and physiological studies of calcium-activated chloride channels

Project Summary/Abstract Not applicable. No change from Parent Award.

Public health relevance
Project Narrative Not applicable. No change from Parent Award.